International Society of Exposure Analysis (ISEA) 2005 Conference

DESCRIPTION (provided by applicant) International Society of Exposure Analysis (ISEA) is the pre-eminent professional society in environmental exposure analysis, the interactions of environmental exposures to health, and disparities involved. It is involved in environment-gene interactions in producing various health effects (e.g., cancer, reproductive and behavioral) in general and susceptible populations (including children). The annual meetings represent unique opportunities for interaction among research leaders in the fields of environment and health. The 15th annual conference of the ISEA will be held in Tucson, Arizona, from Sunday, October 30 through Thursday, November 3, 2005. The conference will be held under the common theme "Diversity". The theme, Diversity, reflects the diversity of exposures and exposure analysis, and diversity of exposure and health responses that affect some populations more than others. This theme will be enhanced by the participation of professionals from Mexico and other less-developed countries and by the invitation to community partners to attend and engage in meaningful dialogue. ISEA was established in 1989 to foster and advance the science of exposure analysis related to environmental contaminants, both for human populations and ecosystems. The membership promotes communication and coordination among all disciplines involved in the environment, exposure analysis, and health. It includes approaches to address substantive or methodological concerns, strengthen environmental health sciences, and works to strengthen the impact of exposure assessment on environmental policy to protect all. In addition to the abstract book, various publications will result from the conference to disseminate knowledge. The investigator plans to incorporate some of the findings, evaluations, and data on the website as well. The 15th annual conference of ISEA will include keynote addresses, technical workshops, thematic and technical symposia and sessions, and training. New and innovative knowledge, technologies and application of scientific approaches will be addressed at the conference. This will facilitate cross-fertilization of new ideas across the usual narrowly defined disciplinary boundaries, as well as providing a forum for broader interactions among members, other environmental health professionals, and the public.